The Psychiatric Cell Map Initiative: Connecting Genomics, Subcellular Networks, and Higher Order Phenotypes

SUMMARY
The global burden of mental illness, including autism spectrum disorders (ASD), intellectual disability, epilepsy,
Tourette disorder, schizophrenia and bipolar disorder, is enormous, whether measured in health care
expenditures, lost productivity, or personal suffering. Unfortunately, there is a striking lack of insight into the
underlying molecular biology of these syndromes. However, recent advances in gene discovery are setting the
stage for a transformation in the understanding of these psychiatric disorders.
Understanding pathobiology and developing novel treatments is becoming increasingly dependent on
knowledge of biological networks of multiple types, including physical interactions among proteins and
synthetic­lethal and epistatic interactions among genes. Here we seek support for a new effort, the Psychiatric
Cell Map Initiative (PCMI, www.pcmi.ucsf.edu), aimed at comprehensively understanding these complex
interactions in psychiatric disorders and how they differ between diseased and healthy states. While we will
focus on ASD in this proposal, this work will establish a paradigm to investigate other psychiatric disorders in
future work. The PCMI is a multi­campus initiative of the University of California, involving UC San Francisco,
UC San Diego and UC Berkeley, which leverages genomics, proteomics, high­throughput sequencing,
advanced network mapping, computational analysis, and research platforms developed by multiple PCMI
investigators over the past decade. Thus primed, these platforms will be tuned to efficiently generate,
assemble, and analyze molecular networks linked to ASD, in relevant cell types, with a view towards pathway
and network­based personalized therapy. Specifically, over the next five years the PCMI will seek to catalyze
major phase transitions in ASD research and therapy by (1) Comprehensively mapping the networks of
physical interactions among proteins linked to ASD, revealing the protein complexes and higher­order
molecular units underlying ASD in multiple cell types of the human brain; (2) Mapping the parallel networks of
synthetic­lethal and epistatic interactions among ASD genes using CRISPR­based approaches; (3)
Establishing the robust computational methodology, end­user software, and databases for assembly and use of
ASD cell network maps in both basic and clinical modalities; (4) Translating molecular insights into an
understanding of higher order phenotypes; (5) Building a critical mass of leading investigators focused on
psychiatric disorders worldwide to expand PCMI into a global coordinated partnership; and (6) Training the
current and next­generation of scientists in Network Biology and its applications to research focused on
psychiatric disorders.

Public health relevance
NARRATIVE Although the past few years have ushered in much success in identifying the genes linked to autism spectrum disorders (ASD), we need to move beyond simply cataloguing component genes in order to gain a mechanistic and actionable understanding of ASD and other psychiatric disorders. More specifically, it is critical to understand the many interactions between these genes and the proteins they encode, and how these complex networks are connected to the underlying pathobiology of ASD. To address this challenge, the Psychiatric Cell Map Initiative (PCMI, www.pcmi.ucsf.edu) will apply systematic approaches to comprehensively map the molecular networks that underlie ASD and translate them to higher order biological insights, which will form a key resource for precision medicine.